Project 1: Improving Immunotherapy in pancreatic NETs

Project 1 – Summary
There is a persistent, unmet clinical need for more effective therapies to treat and potentially cure advanced
NETs. Pancreatic NETs (pNETs) are among the most common types of NETs and have risen 4-fold in
incidence over the last few decades. Immune checkpoint inhibitor (ICI) therapies can provide sustained anti-
tumor responses and improve survival for other tumor types, but trials assessing anti-PD-1 (ICI antibody)
monotherapies have failed in pNET patients. Likewise, trials assessing single agent inhibitors of cyclin-
dependent kinase 4/6 (CDK4/6), which are hyperactivated in pNETs, have been unsuccessful in these patients.
This proposal explores a new approach to sensitize pNETs to ICI therapy – combining immunomodulatory
CDK4/6 inhibitors with ICI antibodies to achieve synergistic antitumor immunity.
This combination strategy seeks to increase T cell activation in tumors by targeting kinases whose
inhibition provokes B and/or plasma cell infiltration. Growing evidence from other tumor types suggests
intratumoral B/plasma cells promote T cell activation by increasing formation of tertiary lymphoid structures
(TLS). TLS correlate with better response to ICI therapy and improved patient survival. These connections
have never been examined in NETs and the anti-tumor role of plasma cells, specifically, has never been tested
in any cancer. In pilot studies, pharmacological blockade of the CDK4/6 pathway using MEK and CDK4/6
inhibitors induced B/plasma cell tumor infiltration and robust tumor regression in an immune competent model
of functional pNETs (insulinoma). Additional pilot studies showed CDK4/6 blockade sensitized pNETs to ICI
therapy targeting programmed death ligand 1 (PD-L1). Three aims will test the central hypothesis that
B/plasma cell tumor infiltration due to CDK4/6 blockade enhances anti-tumor immunity and improves
the efficacy of ICI therapy in pNETs.
• Aim 1. Determine associations between B/plasma cell tumor infiltrates with other immune features,
clinical variables and molecular signatures in patient pNETs.
• Aim 2. Define the efficacy of CDK4/6 blockade and role of B/plasma cell tumor infiltrates in sensitizing
pNETs to ICI therapies in preclinical models.
• Aim 3. Conduct a Phase 1b Window of Opportunity Trial in pre-operative pNET patients measuring the
effects of CDK4/6 inhibitor plus ICI therapy on immune cell tumor infiltration and activation.
The therapeutic combination of CDK4/6 blockade with ICI agents offers the promise of sustained anti-tumor
activity, extended patient survival, and potential cure for patients with advanced pNETs. This project will
advance our understanding of B/plasma cell infiltrates in pNET biology and may identify new prognostic and
predictive NET biomarkers. Studies will also determine, for the first time in any tumor type, the necessity of
plasma cells in pNET anti-tumor immunity, which has broad implications for all solid tumors.

Public health relevance
P1 – Project Narrative The role of B and/or plasma cells in pancreatic neuroendocrine tumor (pNET) biology is unknown, but in other types of tumors their presence is associated with better patient survival and improved response to immune checkpoint inhibitor (ICI) therapy. This project will determine the significance of B/plasma cell tumor infiltrates in pNET biology and patient outcomes while testing, for the first time, if induction of B/plasma cell tumor infiltration by cyclin-dependent kinase 4/6 (CDK4/6) blockade enhances antitumor immunity and efficacy of ICI therapy in pNETs. Findings from novel mouse pNET models and a window of opportunity trial in pNET patients may define a new strategy to sensitize pNETs to ICI agents, thereby offering the promise of sustained anti- tumor activity, extended patient survival, and potential cure.